Clinical Trials Operations Support Center (CTOSC)

Task Order 1 Purpose: To provide CTOSC services which include management, tracking, and oversight of clinical trials funded by the NIA, administrative functions regarding participants' safety, study operations, data quality, and statistical support for NIA funded clinical trials, and training for NIA staff in clinical trial procedures.